Sigma 1 receptor as therapeutic target for Alzheimers disease treatment

ABSTRACT
The broad, long-term objective of this grant application is to understand the mechanisms involved in
neuroprotective action of sigma 1 receptor (S1R) agonists Alzheimer’s disease (AD). Recent clinical and
preclinical data suggest that activation of S1R may promote neuronal resilience and result in synaptoprotective
and neuroprotective effects within an AD context. Mutations in S1R are linked with degeneration of motor
neurons and polymorphisms in SIGMA1R gene have been linked with the risk of developing late onset AD.
These links have prompted on-going and planned phase 2 and phase 3 clinical trials of S1R agonists in AD
patients. Despite its importance for neuronal physiology and as a drug target, the biological function of S1R is
poorly understood and mechanism of action of S1R agonists in preclinical and clinical studies is not well
established. The main aim of this grant proposal is to evaluate the hypothesis that synaptoprotective
and neuroprotective effects of S1R agonists in AD are mediated in part by their remodeling of
mitochondria-associated membranes (MAMs) and other endoplasmic reticulum (ER) cholesterol-rich
microdomains. This hypothesis is based on our recent discovery of biological importance of S1R association
with cholesterol and its role in forming MAMs and ER microdomains. To test this hypothesis, specifically we
will (1) investigate an importance of cholesterol-binding site in S1R sequence for in vivo synaptic rescue in AD
mice; (2) analyze effects of S1R activation on changes of lipid composition of MAMs in AD; (3) determine a
role of enhanced ApoE release from astrocytes for neuroprotective effects of S1R agonists; (4) establish an
importance of neuronal calcium signaling changes resulting from S1R activation. Results obtained in the
proposed studies will provide essential information regarding mechanism of action of S1R agonists in models
of AD, facilitate interpretation of on-going AD clinical trials of S1R agonists, and potentially lead to development
of the next generation of S1R-targeting therapeutic agents for AD treatment.

Public health relevance
PROJECT NARRATIVE The proposed project will have direct and immediate relevance for public health. Alzheimer’s disease (AD) is a major cause of dementia in the elderly and an enormous health problem. Targeting sigma 1 receptor (S1R) is one of the approaches currently tested in AD clinical trials, but the the biological function of S1R is poorly understood and mechanism of action of S1R agonists in preclinical and clinical studies is not well established. Results obtained in the proposed studies will provide essential information regarding mechanism of action of S1R agonists in models of AD, facilitate interpretation of on-going AD clinical trials of S1R agonists, and potentially lead to development of the next generation of S1R-targeting therapeutic agents for AD treatment.